Mitochondrial Modulation Therapy After Brain Trauma

Abstract
Traumatic brain injury (TBI) is a leading cause of death and disability, affecting as many as 1.7
million Americans annually. TBI is a complex and heterogeneous injury that can cause permanent
neurological complications and death. The pathophysiology of the progressive secondary injury
has been well-studied, revealing a highly complex program of overlapping and sequential
processes that leads to ongoing cell death. Despite the heterogeneity in TBI, mitochondria have
been identified as a common effector in the cascade to neuronal injury. Following acute
neurological injury, post-translational modifications of the electron transport can cause sustained
and pathological hyper-activity that generates reactive oxygen species (ROS). Under
physiological conditions, mitochondria are strictly maintained through dynamic restructuring and
turnover, however dysfunction of these systems is implicated in neurological injury. We have
discovered wavelengths of near infrared light (NIR) that partially inhibit cytochrome c oxidase
(COX), the rate liming enzyme in the electron transport chain. We have demonstrated this
inhibitory effect provides robust neuroprotection in acute neurological injury by preventing
mitochondrial hyperactivation and mitigating ROS generation. Our objective in this study will build
on our extensive preliminary data by capitalizing expertise from our interdisciplinary research
team to: (1) Explore the molecular mechanisms of neurotrauma and therapeutic NIR on
mitochondrial dynamics and turnover. (2) Parse the cell-specific mechanisms of NIR therapy
following TBI within the constituents of the neurovascular unit. (3) Expand the understanding of
therapeutic NIR through alternative treatment application strategies following TBI.

Public health relevance
Project Narrative Traumatic brain injury (TBI) poses a substantial health and economic burden, affecting people of all backgrounds, however there have been no treatments approved for use in human patients. Based on discoveries made in our lab, we have developed a non-invasive therapy that has demonstrated robust protection by modulating mitochondrial function. We propose to explore the effects of our therapy on the health of mitochondrial in brain cells to push development towards FDA approval and clinical deployment.